Core 3: Bioinformatics and Analysis Core

Project Summary – Core 3
The Bioinformatics and Analysis (BIA) Core serves as a support network for all VCU Alcohol Research Center
(ARC) projects and will interact closely with each component to provide computational, statistical, and research
design expertise. The core will play a central role in the data collection, curation, annotation, management,
storage, and analysis. As such, we will first collect and curate project related data include those generated by
the VCU-ARC and those that are available from other outside sources. Examples of these internal and external
data include human association studies and expression and network analyses for mouse, worm and fly. The
collected data will be integrated via a data management system. Many statistical and bioinformatics analyses
will be performed for the identification of Alcohol Use Disorders (AUD) related genes, including within and
across species gene network analysis. The core will also implement methods for prioritizing genes for
additional study. The overall goal of facilitating data sharing and the application of emerging methods will be to
accelerate the understanding of AUD and related traits. To this end, a wide range of experimental data and
results related to alcohol will be used and generated by the proposed center. Collecting and integrating these
data provides the opportunity to discover patterns that would be detected when considering a single organism
or experimental design.